Alloimmunization and Humoral Immune Response to Hemolysis and EPO

Blood transfusions remain a cornerstone treatment in sickle cell disease (SCD). However, 15-50% of these
patients develop alloantibodies causing complications ranging from difficulty in finding matched units, increased
risk of autoantibody production (~12% in our patient cohort) to potentially life-threatening delayed hemolytic
transfusion reactions (DHTR). Elevated EPO levels and intravascular hemolysis are two hallmarks of SCD. Our
preliminary data indicate that EPO leads to upregulation of plasma asparagine (Asn) in SCD. EPO-derived Asn
increased anti-RBC immune responses by targeting key B cell subsets and T follicular regulatory cell (TFR) which
was counteracted by hemolysis. Our overall hypothesis is that the balance between EPO/Asn and hemolysis
activation pathways in SCD dictate the risk of allo- and autoimmunization and DHTR in SCD. To test our
hypothesis, we will use our in vivo and in vitro models including studies of SCD patients receiving transfusions
to establish whether: i) EPO/Asn increases whereas hemolysis lowers alloimmunization risk (Aim1) in naïve
B cells through up- or downregulation of Src family kinase (SFK) activation, respectively; ii) heme-driven
mitochondrial dysfunction in memory B cells modulates DHTR risk in alloimmunized SCD patients (Aim1); iii)
EPO/Asn increases autoanti-RBC antibody production (Aim2) by inducing splenic pre-B cell expansion
through SFK pathway; iv) EPO/Asn driven decrease in TFR numbers in SCD occurs by activation-induced
apoptosis through HPK1 pathway but hemolysis increases TFR inhibitory activity through upregulation of HO-1
but only in non-alloimmunized SCD patients. Altogether, we believe that our proposed studies to dissect
mechanistically the role of EPO/Asn and hemolysis in anti-RBC humoral immune response in SCD has potential
to identify biomarkers and therapeutic strategies for diagnosis and reversal of pathologic transfusion responses
in SCD.

Public health relevance
Alloimmunization poses a major barrier to safe transfusions in patients with sickle cells disease and can lead to life-threatening complications. We plan to examine how elevated hemolysis and erythropoietin, two key hallmarks of sickle cell disease, affect components of the immune system that are responsible for antibody responses to transfusions, thereby identifying potential therapeutic strategies for prevention of reactions against transfused, life-saving blood for this vulnerable patient population.